Retinotopic-to-egocentric transformation in visuoparietal cortex

Project Summary
To perceive and interact with a complex and changing environment, animals use visual inputs to build an internal
model of their local space. Early visual regions one or two synapses from the retina represent object locations
in a retinotopic reference frame preserving the relative topography of retinal photoreceptors. Significant cortical
processing is required to transform these object representations to an egocentric reference frame found in
association cortex, in which object locations are mapped relative to the animal’s head or body. The neural
circuitry underlying this critical transformation is not well understood, especially under conditions of active visual
sampling. Computational models have proposed that egocentric object location can be calculated by integrating
retinotopic location and gaze orientation in a multi-layer artificial neural network. This model makes testable
predictions about the neuron response types that would be expected in the intermediate steps of reference frame
transformation. In this proposal, I will use two-photon calcium imaging to record the activity of large populations
of cortical neurons as mice locomote within a chamber containing a salient visual object. By measuring eye
movements and the location of the object relative to the animal, I will develop an analysis approach for
distinguishing retinotopic and egocentric object vector tuning in large populations of cortical neurons spanning
visuoparietal cortex. I will first map the distribution of reference frame coding between primary visual cortex (V1)
and posterior parietal cortex (PPC) to determine which neural populations compute this transformation (Aim 1).
To determine how retinotopic position and eye position signals are integrated within single neurons which show
joint coding for multiple behavioral variables, I will record the functional calcium activity of dendritic spines in
animals with sparse calcium indicator expression (Aim 2). Together, these results will reveal the biological
implementations underlying reference frame transformation in the mammalian cortex. In understanding this
canonical computation, we will better understand how visual deficits contribute to deficits in spatial perception
and navigation.

Public health relevance
Project Narrative Animals use eye and head movements to sample visual information from their local space, and use this input to create a three-dimensional model of the local spatial environment. Using novel multiphoton imaging approaches in locomoting mice, we will investigate the cortical circuits responsible for transforming visual information into a head-centered map of local space during active sensory samling. These results will advance our understanding of a fundamental computation necessary for visual and spatial perception, and inform technologies to aid people with visual impairments in navigating through their environment.